Propagation and Characterization of Phage Related to Human Growth

Project Description
Bacteriophage (phage) are viruses that infect prokaryotes. Bacteriophage can destroy the bacterial cell
they infect (bacteriolysis), and thereby mold bacterial populations. Our incomplete knowledge of phage
biology, in particular phage-bacterial pairing, the range of bacterial hosts for a given phage, and the effect of an
introduced phage on phage-bacteria community dynamics limits our ability to understand how phage impact
gut health. The human gut contains a highly complex community of bacteria and phage. Alterations in
bacteriophage communities are associated with disorders such as inflammatory bowel disease, diabetes,
hypertension, and colorectal cancer.
Stunting (poor linear growth) adversely affects one-third of the half-billion preschool children in low and
middle-income countries and is associated with ~20% of all-cause deaths before age five. Stunting is believed
to be a consequence of environmental enteric dysfunction (EED). We recently defined the comprehensive gut
virome and the bacterial gut microbiome in a longitudinal cohort of rural Malawian children with EED.
We found 13 bacteriophage that were differentially associated with linear growth. Twelve of the 13
bacteriophage were associated with subsequent poor growth velocity. Intriguingly, we found an inverse
relationship between bacteria and bacteriophage richness in children with subsequent poor linear growth
(bacteriophage richness diminishes as bacterial richness increases in children with poor growth). Our data
suggest that disruption of the equilibrium between bacteria and bacteriophage communities might impair
childhood linear growth.
This observation that changes in the phage community are associated with subsequent linear growth is
intriguing as there is currently no way to treat or prevent EED and stunting. Additionally, the pathophysiology
underlying EED is not well understood, and there currently is not a reliable marker of disease. Therefore,
further understanding of these bacteriophage as either drivers or markers of disease would be a significant
advance for the field. We suggest that further characterization, and potentially future manipulation, of these
microbial signatures may reveal novel avenues for prevention, diagnosis, or treatment of EED and stunting.
Here we aim to advance understanding of phage biology, global gut health, and child health and development.
We will identify and grow bacterial host(s) of the phages of interest, culture phages, and further characterize
them. While we propose to apply our methods to study phage in the context of EED, execution of this
approach will also provide a much-needed roadmap for future studies of phage in other disorders.

Public health relevance
Project Narrative We recently identified 13 bacterial viruses (bacteriophage) that predict good versus poor growth in children with environmental enteric dysfunction. How each of these bacteriophage interact with the bacterial microbiome is not known. Here, we will define their bacterial hosts, then culture and further characterize these bacteriophage to begin to determine their contributions to health and disease.